A home-based intervention to improve adherence to the 24-Hour Movement Guidelines in young children

PROJECT SUMMARY
Few young children meet the recently adopted World Health Organization recommendations for movement
behaviors (physical activity, sleep, and screen-time), known as the 24-Hour Movement Guidelines. This
inadequate balance of movement behaviors places children at risk for more behavioral problems, poor cognitive
development, delayed motor skills, and obesity. Minority children and children who live in low-income household
are at increased risk of meeting few recommendations, and consequently these long-term health outcomes.
Pitfalls of current literature include focusing on one behavior at a time and neglecting the context in which these
behaviors occur. Ecological momentary assessment (EMA) and mHealth tools are ideally positioned to address
this gap, by assessing and addressing movement behaviors in real-time and within the home, where all three
movement behaviors occur. Using mixed methods, this study aims to identify patterns (amount and context) of
child movement behaviors within the home via EMA paired with a child-worn accelerometer and identify barriers
and facilitators to changing these behaviors within the home via semi-structured interviews (Research Aim 1).
Behavior change theory, previous literature, and an iterative process using parent feedback will inform the design
of a movement behavior intervention delivered through a mHealth modality (e.g., mobile app, Research Aim 2).
Finally, this study will then pilot test the preliminary effectiveness and feasibility of this intervention in a
randomized control trial with the goal of meeting all three movement behavior recommendations, thus the 24-
Hour Movement Guidelines (Research Aim 3). To complement these research aims, the candidate will receive
didactic, hands-on, and applied research training in EMA, mHealth, and interventional research amongst diverse
populations (Training Aim 1), along with behavior change theory and child behavior and cognitive development
(Training Aim 2). The candidate will expand her network and presence, and scientific prowess in writing grants
and mentoring to propel her into a future career as a 24-Hour Movement expert (Training Aim 3). Experts in
these respective fields, who are also seasoned mentors, will guide her through these research and training aims,
and ultimately into an independent position and research career. This experience will culminate in data for the
candidate to build her independent research program, with the goal of improving child movement behaviors, and
ultimately their long-term health.

Public health relevance
PROJECT NARRATIVE Few young children meet the recently adopted World Health Organization recommendations for movement behaviors (physical activity, sleep, and screen-time), known as the 24-Hour Movement Guidelines, putting children at risk for more behavioral problems, poor cognitive development, delayed motor skills, and obesity. This study will advance current literature by addressing all three behaviors together and within the setting where all three behaviors occur, the home. This pilot study will evaluate the feasibility and preliminary effectiveness of a theoretically grounded and home-based mHealth intervention to improve adherence to the 24-Hour Movement Guideline, and ultimately child mental and physical health.